Gastrointestinal Tract XXI

Project summary/abstract
This application requests partial support for a FASEB Scientific Research Conference entitled “Gastrointestinal
Tract XXI: "Life, Death and Disease of the Gut” that is scheduled for September 8-12, 2024 in Banff, Alberta,
Canada. The meeting will convene a diverse group of speakers, including many women, underrepresented
groups, and young investigators, to discuss the biology of the gastrointestinal tract and its dysregulation in the
setting of disease. A keynote address plus eight lecture sessions will address gastrointestinal stem cell
homeostasis and plasticity in response to injury/disease, nutrition and metabolism, novel approaches using GI
organoids, the microbiota-gut-brain axis, epithelial physiology, microbial homeostasis, mucosal inflammation,
IBD, and cancer. Ample time will be set aside for discussions amongst participants, and the presentation of
unpublished data will be prioritized. There will also be two poster sessions as well as several career development
activities for early career investigators and trainees, and opportunities to promote the visibility of these individuals
who represent the future of the field. We have assembled an innovative program with committed participation
from leaders with diverse expertise within GI-related research fields. Overall, in an intimate and secluded setting
that encourages informal interactions between scientists at all levels, we provide an innovative approach to the
exchange of ideas and synthesis of science that will move the field of GI research forward. The conference has
a 39-year track record of serving as a foundational meeting for trainees as evidenced by year-after-year
attendance by those who have matriculated in research-related careers spanning from basic science discovery
to clinical significance for GI health and disease. It is therefore expected that the meeting will provide new insights
not only into basic gastrointestinal physiology, neurobiology, developmental biology, and microbiology, but also
how to treat, and ultimately cure, a wide variety of digestive disease states.

Public health relevance
Project narrative This application requests partial support for a FASEB Scientific Research Conference entitled “Gastrointestinal Tract XXI: "Life, Death and Disease of the Gut” that is scheduled for September 8-12, 2024 in Banff, Alberta, Canada. The goal of this meeting is to bring together basic science, translational and clinical researchers to discuss the most up-to-date scientific discoveries that pertain to the gastrointestinal system and its regulatory mechanisms. Beyond the scientific sessions, there will also be a focus on career development activities to enhance the professional progression of early-stage researchers and those who are new to the field, and the information shared should promote new understanding of, and treatments for, digestive diseases.